Host-pathogen interactions during Staphylococcus aureus spine infections

PROJECT SUMMARY
Staphylococcus aureus (S. aureus), a leading global pathogen, is the primary microorganism implicated
in spine infection. Because patients’ backpain symptoms are often misdiagnosed, paralysis may ensue in up to
75% of patients, and up to one-third of them may die from the disease. Despite recognition of the severe
disease morbidity and mortality, the molecular mechanism of human spine infection remains undefined.
S. aureus-human coevolution likely favor selection of isolates that are adept at virulence factor
regulation adapt to the human host. One such adaptation is the ability to interfere with the C5a-hC5aR1 axis, a
powerful component of the human innate immune system, through the production of three human-specific
virulence factors, the Panton-Valentine Leukocidin (LukSF-PV/PL), γ-hemolysin CB (HlgCB), and the
Chemotaxis Inhibitory Protein of S. aureus (CHIPS). These toxins target hC5aR1 to prevent C5a binding, thus
disrupting neutrophil chemotaxis and function, enabling pathogen evasion of host killing. Up until now, species-
specific receptor limitations have hindered accurate modeling of the effects of these toxins. However, the
development of a novel humanized mouse model with knock-in hC5R1 (hC5aR1KI) set the stage for us to
evaluate their contributions in invasive S. aureus infection.
When we evaluated S. aureus bacteremia in wild-type and hC5aR1KI mice, we observed that hC5aR1KI
mice developed highly penetrant mobility deficits involving the hindlimbs owing to infection of the spine, an
important complication of S. aureus bacteremia in humans. We further dissected the contribution of each
hC5aR1 targeting virulence factor, as well as examined the contribution of other S. aureus virulence factors,
and implicated CHIPS and at least one of the 21 sortase A dependent cell wall-anchored surface proteins
(SADCASP) as critical contributors to spine infection.
To evaluate the roles of CHIPS and SADCASP in human spine infection, I will: 1) Clarify the role of
surface proteins in spine infection, and prepare to test my hypothesis that immune interference and immune
evasion properties of SADCASP and CHIPS contribute to their success in spine infection. 2) Determine the
mechanism of injury in S. aureus spine infection with respect to CHIPS and SADCASP, and evaluate how
CHIPS’ interference with C5a-hC5aR1 and SADCASP’s immune evasion properties contribute to primary and
secondary spinal cord injury. With a better understanding of how CHIPS and SADCASP promote spine
infection, I will 3) Explore vaccination approaches targeting CHIPS.
Using a novel and clinically relevant mouse model of S. aureus infection, I hope to better understand
the mechanisms behind how CHIPS and the SADCASP empower S. aureus to cause spine infection in
humans, and use this information to identify potential vaccination strategies to prevent its debilitating impact.

Public health relevance
PROJECT NARRATIVE Using a novel mouse model harboring knock-in human cellular receptor (hC5aR1KI) for the C5a complement component of the innate immune system to evaluate the effects of three human-specific Staphylococcus aureus (S. aureus) virulence factors in S. aureus bacteremia, we implicated the Chemotaxis Inhibitory Protein of S. aureus (CHIPS) and at least one of the sortase A dependent cell wall-anchored surface proteins (SADCASP) as critical virulence factors in infection of the spine. We will proceed to test the hypothesis that immune interference and immune evasion properties of CHIPS and SADCASP contribute to S. aureus’ success in spine infection, and to determine how these properties underwrite primary and secondary spinal cord injury. With an improved understanding of how CHIPS promotes spine infection, we will evaluate vaccination strategies targeting CHIPS.